IND-enabling Preclinical Development of a Sustained-release Pritelivir Intravaginal ring for the Treatment and Prophylaxis of Genital Herpes

SUMMARY
The broad, long-term goal of this project is to develop a pritelivir intravaginal ring (IVR) for the treatment and
pre-exposure prophylaxis of genital herpes, a common problem that affects more than 30 million Americans.
Recurrences are common and may be painful, and infection is life-long, yet few treatment options exist.
Pritelivir is a promising α-helicase inhibitor that has been proven superior to existing therapies in Phase 2
clinical trials, but whose clinical development as a systemic therapy has been slowed due to observed
unexplained systemic toxicity in primates. Therefore, pritelivir-based local therapy is of special interest.
We have developed a platform technology for the sustained release of antivirals. This technology has
successfully led to the development and commercialization of a ganciclovir intraocular implant – Vitrasert®, for
the treatment of AIDS-related cytomegalovirus retinitis. This platform has been adapted to IVRs and through its
use we have successfully delivered other antiviral agents at therapeutic levels in preclinical and clinical trials.
We seek to utilize this platform to develop a sustained release IVR formulation for pritelivir. We achieved the
specific aims of our Phase I and II SBIR, which were to: formulate pritelivir-releasing IVRs; test their in vitro
release and in vivo safety and pharmacokinetics (PK) in animals; perform chemistry, manufacturing, and
controls (CMC) activities; develop clinical documents; and submit an Investigational New Drug (IND)
application to the FDA. The successful completion of this Phase I/II SBIR work has enabled us to identify an
IVR dose for the further development of a drug product that is safe and demonstrates sustained release for 28
days and at clinically relevant levels. The IND has been placed on Clinical Hold, pending completion of
additional nonclinical pharmacology and toxicology studies, CMC testing, and device evaluation. We, therefore,
propose in Phase IIB to accomplish the FDA-guided nonclinical activities required to enable an IND allowance.
The proposed Specific Aims of this Phase IIB SBIR are to: develop GMP-grade manufacturing capacity for the
drug substance; conduct pharmacology and toxicology studies in rodents and nonrodents; manufacture GMP-
grade drug product; perform device testing in accordance with CRDH’s comments; and re-submit an IND
application to the FDA. The milestone for the successful completion of the proposed Phase IIB work is the
approval of an IND to perform a first-in-human exploratory clinical trial for a pritelivir IVR. In future work, we will
test the lead formulation for safety and PK in female volunteers in accordance with our FDA-approved clinical
protocol. The team of investigators are experts in drug development, synthetic chemistry, pharmacokinetics,
and clinical infectious disease, and have experience collaborating with large pharmaceutical companies to
enable New Drug Approvals (NDAs) of novel drug delivery systems. This project could lead rapidly to the
development of an improved treatment and prophylaxis for genital herpes.

Public health relevance
NARRATIVE The broad, long-term goal of this project is to develop a pritelivir intravaginal ring (IVR) for the treatment and pre-exposure prophylaxis of genital herpes, a common problem that affects millions of Americans. On average, recurrences occur 4 times a year, and infection is life-long. Pritelivir is a promising α-helicase inhibitor that has proved superior to existing therapies in Phase 2 clinical testing, but whose clinical development as a systemic therapy has been slowed due to observed unexplained systemic toxicity in primates. Local therapy is therefore of special interest. Using our proprietary Versa technology platform, we have developed an intravaginal ring (IVR) formulation of pritelivir. The goal of this Phase IIB SBIR proposal is to follow the FDA-instructed nonclinical activities and achieve an Investigational New Drug (IND) allowance in pursuit of clinical testing of our pritelivir IVR product in humans.